Investigating the role of prefrontal cortex circuits in opioid-induced risk-taking behavior

Project Summary
Despite the widely publicized risks of non-medical opioid use, opioid misuse continues to be a serious health
problem affecting a significant parcel of the population in the United States. While opioid use disorder has been
linked to abnormal risk-related decision making, the causal mechanisms underlying this relationship remain
unclear. Both human and animal studies suggest that aberrant activity in the brain's prefrontal cortex (PFC) may
contribute to the risky choice behavior induced by repeated opioid exposure. Particularly, the prelimbic subregion
(PL) of the PFC has been implicated in both the rewarding effects and the subsequent behavioral changes
induced by opioids. Previous neuroanatomical studies have shown that PL neurons send dense projections to
the nucleus accumbens (NAc), a region implicated in behavioral motivation and maladaptive opioid seeking.
Additionally, the PL projects densely to the paraventricular nucleus of the thalamus (PVT), a region involved in
behavioral conflict and the negative emotional aspects of opioid withdrawal. However, how opioids alter the
function of these two distinct PL pathways to elicit risky drug seeking remains unexplored. I will address this
question by using a novel model of opioid-induced risk-taking behavior in which rats will be exposed to a conflict
between seeking opioids and avoiding a fearful stimulus. In Aim 1, I will investigate individual variabilities in risky
decision making and determine which behaviors predict risky choice during a conflict situation. In Aim 2, I will
combine optogenetic and electrophysiological techniques to record the activity of PL neurons that project to
either the NAc (PL-NAc) or the PVT (PL-PVT) during the conflict test. Finally, in Aim 3, I will establish the role of
PL-NAc and PL-PVT projections in opioid-induced risk taking by using optogenetics to either inhibit or excite
these circuits during conflict and characterize the resultant behavior. This project will allow me to uncover the
PFC underpinnings of opioid-induced risky decision making, which may help us to understand how repeated
opioid exposure affects motivated behaviors in humans.

Public health relevance
Project Narrative Opioid use disorder is characterized by continued use of the drugs despite a knowledge of negative consequences. This project will entail careful investigation of prefrontal cortex circuits involved in opioid-induced risk-taking behavior in rats. Because the proposed experiments include recordings and manipulations of prefrontal cortex activity, a brain structure that can be targeted clinically through noninvasive technologies such as transcranial magnetic stimulation, the results may shed light on the development of novel therapies for psychiatric disorders characterized by risky decision making.